Feasibility pilot in preparation for large pragmatic encouragement trial of Bright Light Therapy (BLT) for depression

ABSTRACT
The most common treatments for depression are antidepressant medications (ADs) and psychotherapies such
as cognitive behavioral therapy (CBT). However, these treatments yield only moderate benefits under ideal
circumstances. These effects are further eroded when real world patients initiate treatments at low rates and
have poor adherence or early discontinuation. This represents a depression care gap that supports the
development and promotion of other interventions. One of these alternative treatments, bright light therapy
(BLT), has established efficacy for seasonal affective disorder (SAD) and non-SAD depression, is relatively low
cost, and has few adverse effects—but is often overlooked and has little presence in routine clinical care. This
R34 application is in preparation for a subsequent large, pragmatic trial to examine the effectiveness of bright
light therapy (BLT) for depression when delivered to real-world patients with little “scaffolding” typical of highly
controlled efficacy trials. We will conduct a feasibility pilot with a sample of 90 patients selected with a new
clinical diagnosis of unipolar depression or SAD, or a PHQ-9 score >= 10, recorded in the healthplan’s
electronic health record (EHR). Participants will be randomized to either: Arm 1: Treatment as Usual (TAU): A
“usual care services” control group (e.g., ADs, psychotherapy; all TAU is permitted and will be recorded for all
participants in all conditions); Arm 2: TAU + Minimal BLT Encouragement: TAU plus two minimal written
communications (mailed letter, secure EHR message) promoting BLT as a promising treatment and outlining
steps for patients to self-initiate; Arm 2 will not include any phone coaching or adherence promotion; or Arm 3:
TAU + Enhanced BLT Encouragement + Adherence Promotion: TAU plus 2-4 brief calls to encourage BLT
use, advise on purchase of a light box (LB), assist with obtaining insurance reimbursement, educate for correct
LB use, and provide motivational interviewing (MI) as needed to promote adherence. The primary outcome is
PHQ-9 self-reported depression symptoms; the primary test of BLT effectiveness is the contrast between Arms
2+3 vs. Arm 1. We will conduct exploratory analyses to prepare for a future fully-powered trial. We will examine
other secondary outcomes including anxiety, disability, and mood seasonality, and other secondary contrasts;
e.g., Arm 2 vs Arm 3. We will also examine moderation effects; variation of BLT effects in subgroups (e.g.,
those receiving vs. not receiving TAU antidepressants); and we will examine mechanisms of BLT and MI
intervention effects via candidate mediators including normalized circadian rhythm, improved sleep, and
increased physical activity (for BLT), and readiness for change (for MI). This pilot will yield feasibility products
to assist with successful conduct of a subsequent full trial: estimates of recruitment success, participant
retention, and adherence with BLT protocol; refinement of the adherence promotion protocol; and an estimate
(with wide confidence intervals) of BLT effectiveness.

Public health relevance
PROJECT NARRATIVE Antidepressants and psychotherapies are the most typical treatments for depression, but they are only somewhat helpful and patients are often hesitate to start or continue with these because of side effects, cost, or other reasons. Another promising treatment, bright light therapy (BLT), is proven helpful for seasonal affective disorder (SAD) and non-SAD depression, is relatively low cost, and has few side effects—but it is often overlooked and is not used very much in routine clinical care. This is a small pilot with 90 patients to help us prepare for a much larger study later, and tests how well BLT works with real-world, complicated patients who may need assistance to use treatments in the way that will be most helpful.